Core C: Systems Biology Core

The Systems Biology Core C (SB Core C) serves this P01 Program to provide high-throughput pipelines from
sample acquisition through quality control, library preparation, sequencing, and pre-processing of sequencing
data sets. The main objective of the Core is to generate gene expression data sets for analyses to define the
RHCMV/SIV vaccine response and programming by IL-15 for SIV vaccine protection in rhesus macaque (RM)
vaccine cohorts of pre-clinical studies. Core C will conduct the following Specific Aims: 1) Perform next-
generation sequencing assays of whole blood, tissue, and single cell samples received from Projects 1 and 2;
2) Conduct NanoString nCounter analyses on whole blood samples from Project 1 to assess baseline IL-15
expression and response, and to interrogate the whole blood predictive protective signature to inform study
assignments; 3) Manage big datasets of next-gen sequencing data for quality assurance, analysis, public
database disposition, publication, and Program access. The Core will prepare and/or sequence libraries
generated from tissues for spatial transcriptomics, libraries generated from single cells in blood and tissues for
single cell RNA-seq analysis, and whole immune tissues including whole blood, lymph node (LN), spleen, bone
marrow (BM) and gut-associated lymphoid tissues (GALT) for bulk and single cell RNA-seq analysis, including
CITEseq. The Core will provide consistent, high-quality functional genomics data that will be housed by a secure
data management system. Data generated by the Core will undergo quality control, pre-processing, and
normalized matrix generation prior to being delivered for bioinformatics analyses to support all aspects of the
scientific program.